Cardiac Sensory and Sympathetic Nerve Dysregulation in Hypertrophic Cardiomyopathy

Project Summary
Familial hypertrophic cardiomyopathy (HCM) is the most common genetic heart disease with an estimated
prevalence of 1:500 individuals in the general population. Sarcomere gene mutations result in the
characteristic features of HCM include left ventricular (LV) hypertrophy, myocyte disarray, interstitial fibrosis,
diastolic dysfunction, and high risk of cardiac arrhythmias and sudden death. Indeed, HCM is the number
one cause of sudden cardiac death in young, otherwise healthy adults. Non-invasive treatments for HCM
target symptoms and do not prevent or slow disease progression, underscoring the need for new therapies.
Recently, a new small molecule negative ionotropic agent has shown promise in treating HCM, but long-
term benefits remain to be reported. HCM research has focused primarily on genetics and molecular
mechanisms impacting cardiomyocyte and LV structure and function. Hypercontractile sarcomeres
accompanied by metabolic dysfunction and energy depletion are considered causal mechanisms. We
propose that the aberrant mechanical and metabolic signals produced in HCM hearts are detected by
cardiac sensory nerves, with the resulting abnormal reflexes contributing to acute cardiovascular instability,
chronic and selective increases in sympathetic nerve activity to the heart, decreased parasympathetic
activity, cardiac inflammation, fibrosis, and diastolic dysfunction. We hypothesize that cardiac spinal
afferents (CSAs) in HCM exhibit increased chemosensitivity, reflecting increased [H+] produced by myocyte
energy depletion/ischemia and increased neuronal expression of acid-sensing ion channel 3 (ASIC3). An
alpha tropomyosin mouse model of HCM with cardiac-targeted mutation known to cause HCM in humans
will be studied in male and female mice. Specific aims of the project are: 1) Test the hypothesis that HCM mice
demonstrate a selective increase in cardiac sympathetic tone mediated by the cardiac spinal afferent reflex and
dysfunction of the neuronal norepinephrine transporter, and 2) Test the hypothesis that increased activity of
CSAs is mediated by ASIC3 and targeted cardiac ablation of CSAs will improve cardiac and autonomic
function in HCM mice.The proposed studies using innovative, targeted, and complementary approaches will
close gaps in knowledge regarding mechanisms causing sympathovagal imbalance in HCM prior to heart
failure, the influence of cardiac innervation on the HCM heart, and the quest for disease-modifying therapies
in HCM. Pursuant to the goals of the Academic Research Enhancement Award (R15), this project will also
provide research opportunities in neural-cardiovascular physiology to undergraduate students studying
human health at Michigan Technological University.

Public health relevance
Hypertrophic cardiomyopathy (HCM) is the most common genetic heart disease and number one cause of sudden cardiac death in young adults and athletes. In this project we will test the novel hypothesis that cardiac sensory neurons activated by metabolic signals originating in hypercontractile/energy deficient sarcomeres evoke chronic reflex cardiac sympathovagal imbalance that exacerbates heart damage. We propose a novel treatment targeting the cardiac sensory nerves to disrupt this pathologic positive-feedback reflex.